Stimulating oligodendrocyte progenitor cell differentiation and remyelination

DESCRIPTION (provided by applicant): Currently available immunomodulatory therapies do not modulate the pathogenesis of axonal degeneration once it is established and are only partially effective in preventing the onset of permanent disability in MS patients. Identifying a drug that stimulates endogenous myelination and spares axon degeneration would theoretically reduce the rate of disease progression. We have previously shown that treatment of demyelinating mouse models with estrogen receptor (ER)β ligand, diarylpropionitrile (DPN) has the potential for fulfilling this role. Because DPN is a generic ERβ ligand with low specificity we are screening higher specificity ERβ ligands that are available to the PI through collaborations and material transfer agreements. We propose to examine here, the stimulation of remyelination and the signal transduction pathway activated by the therapeutic effects of commercially available and chemist generated specific ERβ ligands in two different demyelinating mouse models of MS. The central hypothesis of the proposed experiments is that therapeutic treatment with ERβ ligand will cause activation of the IFG1/Akt/mTOR signaling pathway to induce OL survival and endogenous myelination in mouse models of demyelination. This hypothesis will be tested by pursuing two specific aims: The first aim will determine which ERβ ligands induce the most robust remyelination and neuroprotection during therapeutic treatment in mouse models of MS. EAE and CPZ will be therapeutically treated with different commercially available and new ERβ ligands. The two most effective ERβ ligands will be analyzed further for their mechanism of action. The second aim will determine if treatment with different ERβ ligands regulate signaling molecules that affect OL survival and differentiation. Under the first specific aim behavioral (clinical scores and rotarod), immunological (cytokines), demyelination and axonal integrity (electrophysiology, immunohistochemistry, electron microscopy) will be assessed. Under the second specific aim dissected corpus callosum, fluorescence activated and antibody-conjugated microbead sorted OLs from various EAE treatment groups for gene and protein analysis. To verify the effects of ERβ ligand on specifically OLP/OL cells in vivo and gain insight into our mechanistic understanding of how ERβ ligands exert its promyelinating influence during disease, we will use ERβ conditional knock-out mice targeted to OLP/OL cells. In summary, once the aims of our project are achieved, we will not only reveal the best available ERβ ligands, but also reveal their mechanism of action. In addition, exploring OL survival and differentiation related gene and protein analysis along with use of ERβ ligand conditional knock-out mice in OLs allows us to conclude a direct or indirect effect of the drugs. As a neuroprotective agent that enhances myelination, such ERβ-targeted agents could be given in combination with the currently available anti-inflammatory agents.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health because we are identifying and assessing the mechanism of action of a putative therapeutic agent that stimulates endogenous myelination resulting in sparing of axons and clinical protection during demyelinating diseases. The proposed research is relevant to the part of NIH's mission that pertains to the conceptualization, discovery, and preclinical evaluation of innovative therapeutics for nervous system disorders, with the goal of accelerating the development of new treatments for these diseases that will help to reduce the burdens of human disability.